Stanford BSSR Pre-Doctoral Training Program at the Intersection of Data Sciences with Behavioral, Social, and Population Health Research

Project Summary / Abstract
The mission of the Stanford BSSR Pre-Doctoral Training Program at the Intersection of Data Sciences with
Behavioral, Social, and Population Health Research is to develop a cross-campus collaborative training
program to provide talented pre-doctoral students with advanced specialized training at the intersections of
social and behavioral health science, social epidemiology, data science, and population health. We are
building a new team that spans the Stanford campus including faculty from 6 schools and 11 departments. We
will provide a transformative multi-disciplinary predoctoral training environment that draws mentors from
diverse fields (health and social psychology, medical sociology, social epidemiology, communications, health
economics, business, education, law) and quantitative disciplines (computer science, informatics, statistics).
The graduates of our program will have rigorous training in their own scientific disciplines, combined with
extensive expertise working on a broad range of innovative research projects that rely on data of primarily two
types: (1) intensive or voluminous longitudinal data from mHealth, smartphone and sensor technologies or
electronic health records, and/or (2) large and complex data from internet, commercial, health administrative
records, large population databases, internet data and social media platforms, crowd sourcing, and citizen
science data. Predoctoral trainees in their first or second year of graduate studies will be admitted from
programs in health psychology, medical sociology, social/behavioral epidemiology, health economics or
another social science discipline. We are requesting support for 5 pre-doctoral students per year whose
training will last 2 or more years. They will emerge from the program with a thorough understanding of their
own fundamental discipline combined with advanced expertise in cutting-edge statistical and computational
methods for analyzing increasingly complex and multidimensional longitudinal sets. The training program
components will include both department or discipline-specific training in addition to program-wide data
science components including: (1) innovative curriculum, including specialized quantitative curriculum
customized to the experience and background of each trainee; (2) a mentored research experience with a dual
mentor model (one disciplinary mentor, one methodological mentor); (3) exposure to team science approaches
to problem solving, including design thinking, cross-disciplinary collaborations, and team building; (4)
experiential components, including availability of Stanford dry-lab rotations and short-term internships in Silicon
Valley companies; (5) forums for intellectual exchanges; and (6) many opportunities to develop professional
skills in grant writing and collaboration. BSSR graduates will have the capability to conduct cutting edge
research on behavioral and social, and health issues, as well as prevention and treatment interventions that
have the potential to reduce the risks of heart, lung, blood, and sleep (HLBS) disorders and improve outcomes
among patients with these disorders.

Public health relevance
Project Narrative The mission of the Stanford BSSR training grant is to develop a cadre of highly trained behavioral and social scientists with advanced quantitative skills for dealing with complex data, with a focus on applications to heart, lung, blood, and sleep (HLBS) disorders. The BSSR program addresses a critical need to train investigators with primary skills in behavioral and social sciences to have advanced quantitative skills to deal with the increasingly complex large-scale multidimensional data from digital devices, wearables, electronic health records, social media, administrative health claims databases, and other sources.